Career Development of Environmental Health Investigators

The overall goal of the Career Development Program (CDP) is to recruit future leaders in environmental health sciences (EHS), to support their development, and to promote training of investigators at all levels in order to enhance mulfidisciplinary collaborations identifying the causes and reducing the burden of environmental disease.